Multi-scaled Modeling of Electrostatic and Polarization Effects in Biomolecules

PROJECT SUMMARY
Atomistic molecular simulations provide a suite of testable observables that yield essential mechanistic insights
into a variety of diseases, ranging from cancer to neurodegenerative disorders. These insights are vital for the
development of therapeutic strategies. Yet, accurately modeling complex processes such as order-disorder
transitions, ionic interactions, and events at the biomembrane interface remains a formidable challenge with
current methods. This is largely due to the intricate modeling required for electrostatic and polarization effects
across varying structural states and solvent environments – an endeavor that current approaches struggle to
perform efficiently. Our hypothesis to address the accuracy requirement is that biomolecules situated in diverse
chemical contexts are best modeled within a polarizable framework to ensure satisfactory transferability.
Departing from traditional methods, our polarizable Gaussian Multipole (pGM) model represents charges and
multipoles with Hermite-Gaussian functions, rather than the conventional delta functions. This advanced
representation enhances the model's accuracy, self-consistency, and transferability. Nonetheless, a known
drawback of polarization treatments is their tendency to compromise simulation efficiency. To address this, we
are pioneering a multi-scaled framework that integrates all-atom polarizable, coarse-grained polarizable, and
continuum polarizable models. These models are designed for consistent interaction within multi-scaled
simulation methods, facilitating more efficient interfacing. Our plan can be summarized in the following four
areas: (1) the development of pGM force fields; (2) the development of continuum pGM solvent models; (3) the
development of coarse-grained pGM models; and (4) the validation and application of our computational
models to biomedical challenges. We will apply our models to significant biomedical issues, with a particular
focus on biomolecular recognition and its association with conformational changes and allostery. To ensure our
models address the most pressing challenges, such as order-disorder transitions linked to biomolecular
recognition, we will validate them against these complex phenomena. Our commitment extends to the annual
release of new models and tools, aiming to provide a broad and enduring contribution to the biomedical
research community.

Public health relevance
PROJECT NARRATIVE Electrostatic and polarization effects play important roles in all basic biomolecular events and therefore are integral to the modeling of biomolecular structure and function. This project will generate a set of multi-scaled methods and models for computational studies of biomolecules of medical importance. These methods will enable discovery of knowledge on biomedical processes occurring at a wide range of spatial and temporal scales and yield unique opportunities for drug design through detailed mechanistic studies.